The OSU Center for Clinical and Translational Science: Advancing Today's Discoveries to Improve Health

The Ohio State University (OSU) Clinical and Translational Sciences Institute (CSTI) was formed in 2007, with a vision to advance today’s discoveries to improve health for all. We employed a comprehensive approach to address the full spectrum of T1-T4 science via the education and career development of a highly trained workforce integrated with a robust system of CTR resources. We provided leadership in the CTSA Consortium through sharing of tools and methods to advance CTR; adopted innovations from other hubs; and fully engaged in CTSA Consortium activities (e.g., multisite trials). We also supported community engaged research addressing the most pressing health issues in our communities. Yet, work remains. Thus, we build upon unique strengths at OSU/NCH and in Ohio’s communities. We have leveraged our strategic investment in data sciences, a robust environment of resources, and a vibrant CTR community to address CTS gaps and barriers. We will now address five CTS roadblocks to improve the quality, efficiency, and rigor of CTR: (1) need for improved efficiencies and effectiveness to advance CTR and ensure results are disseminated and implemented into healthcare; 2) education and training innovations do not reach the full CTR workforce, resulting in a declining CTS workforce, lacking the knowledge and skills to advance CTR; 3) limited authentic participation by a wide range of stakeholders across the research life cycle; 4) growth of complex datasets necessitates integration of clinical, environmental, and research data, with need for democratization of data accessibility; and 5) need for improved understanding of the contributions of neighborhoods, built environment, education, and financial resources to health outcomes. To address these roadblocks we will pursue five aims: Aim 1: Develop innovations in methods, approaches, and tools to address pressing roadblocks facing CTR. Aim 2: Support training and career development of the full CTS workforce. Aim 3: Engage voices from across academic and scientific disciplines, patients, communities, and industry to conduct CTR and CTS across the full lifecycle of the scientific process. Aim 4: Deploy an accessible, responsive, and integrated system of research resources. Aim 5: Democratize informatics resources by lowering the barriers of entry for data access and computing resources. With a commitment to metric-driven decision-making, we will evaluate the impact of the CTSI by applying the RE-AIM framework to inform strategic pivots over the next 7 years. This proposal reaffirms our commitment to advance CTS and expands our engagement with stakeholders to increase rigorous, impactful, and relevant CTR. We will develop, share, and adopt innovations through focused CTS to enhance CTR for the communities we serve and those we engage. These resources, skilled workforce, and institutional strengths provide an agile foundation to facilitate rapid responses to emerging public health issues and will ensure our laser focus on advancing today’s discoveries to improve health for all.

Public health relevance
This Clinical and Translational Science Award (CTSA) will continue support for The Ohio State University (OSU) Clinical and Translational Science Institute (CTSI) in partnership with Nationwide Children’s Hospital. We will address critical clinical translational roadblocks to provide leadership, education, training, and resources, in collaboration with the CTSA Consortium, to advance today’s discoveries and improve health for all.